Core F -Integrated Support Services Core

Project Summary/Abstract
The goal of this project is to maintain the Galveston National Laboratory (GNL) at the
University of Texas Medical Branch as a part of the NIAID Biodefense Facilities Network
to provide access to maximum containment research facilities for NIAID funded
investigators, academic collaborators from across the nation and around the world,
commercial partners and others as appropriate. This high containment research
infrastructure and associated facilities is required to safely and securely conduct
research that will facilitate the discovery and development of therapeutics, diagnostics
and vaccines for dangerous pathogens requiring biocontainment. This unique resource
is also a critical resource to educate the next generation of experts in infectious
diseases of global health importance. The GNL actively responds to national public
health emergencies by providing rapid assistance in diagnostics, sharing of critical
reagents, and contributing to the discovery and development of effective medical
countermeasures. To achieve this goal, the GNL maintains cores focused on supporting
safe and secure operations and maintenance of maximum containment research
facilities and to provide unique resources and tools to investigators working in
biocontainment to allow them to rapidly, safely and securely address emerging
infectious diseases and bioterrorism threats. Unique capabilities include the ability to
generate and quantify aerosol challenges of laboratory animals from mice to non-human
primates, access to arthropod vector colonies to support zoonotic disease transmission
studies, and state-of-the-art imaging capabilities to visualize findings, among many
others. Working together, GNL teams conduct basic and applied research that can
transition original discoveries from concept to final product development, validation and
licensure.

Public health relevance
Project Narrative National Biocontainment Laboratories Operational Support ensures the availability of maximum containment laboratories for research that will develop the next generation of therapeutics, diagnostics and vaccines for infectious diseases that can pose a public health risk. It also ensures that high containment labs are available in the event of a public health or bioterrorism emergency. This support is essential due to the high cost of building and maintaining laboratories that protect researchers, ensure the biosecurity of dangerous pathogens, and safeguard the communities where these laboratories are located.